Recruitment Core

Abstract – Recruitment Core
CDU’s RCMI AXIS Recruitment Core will recruit two nationally renowned and respected investigators with
expertise in addressing health disparities research. The Recruitment Core, in partnership with the Deans,
Department Chairs, and Faculty at CDU, will conduct a national search that will ensure that applicants from
underrepresented backgrounds are actively sought out. We will engage national and local academic
partners and collaborators. These individuals will have demonstrated track records in obtaining independent
research support as assessed by NIH-R series, P-series, and/or U-series awards.
Supporting the recruited new faculty members' research with our outstanding Research Resource
Core/Precision Medicine together with robust and well-developed Units in Medical Bioinformatics, Methods
and Statistics, Clinical Research and Facilities, Drug Discovery, and Next-Generation Sequencing. In
addition, these individuals will be encouraged to participate with our internal and external partners (please
see Figure 2 in the Administrative Core section).
The proposed work of the recruitment core will benefit developing multidisciplinary, translational research
based on precision medicine and precision health platforms at CDU. These individuals will serve as strong
role models and mentors for junior investigators and by improving the quality of recruitment and retention
processes for junior scientists. They will play a key role in our Investigator Development Core and provide
strong mentoring and career development for our young investigators.